A Device for Detection of Acute Kidney Injury

Summary
This is a revised Phase I STTR application to develop and test a device to predict severe acute kidney injury
(AKI). Prediction of future risk of developing Acute Kidney Injury (AKI) has been a goal for decades. The
treatment of patients with severe AKI and severe AKI that requires dialysis (AKI-3 and AKI-D) is significantly
different than for patients with mild-to-moderate AKI (AKI-1 to AKI-2). No currently available biomarkers are
strong predictors of the development of severe AKI, nor can they differentiate AKI-1 and -2 from AKI-3 and -D.
We have discovered that extensive cleavage of a protein occurs in the urine of patients with mild AKI that will
progress to severe AKI. This cleavage does not occur in healthy controls or patients with mild AKI that will not
progress to severe AKI. Preliminary data suggest that an assay that uses this cleavage to predict severe AKI
will be both highly sensitive and highly specific. In this application, we propose to develop a point of care test
that can detect the amount of cleavage of this protein. We will use this test to predict the future development of
severe AKI.

Public health relevance
Narrative It is difficult to predict which patients will progress to severe acute kidney injury but a test that can make that prediction would be clinically valuable. In this study we will develop a test that can predict the development of severe acute kidney injury and test its accuracy.